Principles in Cardiovascular Research Training Program

Project Summary/Abstract
This application is for the competitive renewal of the “Principles in Cardiovascular Research Training Program”
at Washington University School of Medicine. Since its inception in 1975, this training program has
demonstrated a strong track record of training physician-scientists and scientists who have emerged as
thought leaders in Cardiovascular Medicine. The primary objective of this training program is to provide
multidisciplinary research-based training opportunities, incorporating diverse areas of focus and investigative
modalities to develop independent scientists who are trained to utilize basic, translational, clinical, and/or
health services-focused cardiovascular research principles to improve outcomes of patients with
cardiovascular disease. The re-designed program is focused on training the next generation of physician-
scientists to tackle the resurgence in cardiovascular diseases triggered by the epidemic of obesity and
metabolic syndrome, while ensuring a continued focus on current cardiovascular disease landscape to address
areas of unmet need. The program is housed in an intellectually stimulating and scientifically creative
environment within the Cardiovascular Division and Center for Cardiovascular Research, and benefits from
highly collaborative interactions between 28 faculty mentors that hold appointments in 2 Schools, 8
Departments and 4 Divisions in the Department of Medicine. The faculty are well funded; have been recruited
based upon their multidisciplinary expertise in the six area of focus, namely myocardial biology, inflammation,
vascular pathobiology, ion channel biology, metabolism and genomics, with health care economics and policy
as a unique area of training focus integrating the clinical and services aspects of cardiovascular health; and
demonstrate a strong track record of mentoring. The program objectives are unique as compared with other
training opportunities available within the institution. The current application, which seeks support for 6 MD,
MD-PhD or PhD post-doctoral trainees per year, incorporates many new programmatic features developed to
enhance the training mission and is designed to provide 2-3 years of uninterrupted research training after
completion of core clinical requirements. The curriculum has been re-designed to focus on the major research
themes, with emphasis on Rigor and Reproducibility and Responsible Conduct of Research; and a team-based
approach is encouraged with co-mentoring to enhance interdisciplinary training opportunities. The cornerstone
of training is a rigorous trainee-driven project supervised closely by experienced faculty mentors. Trainees
participate in the weekly Trainee Research Seminar series and the Cardiovascular Research Seminars series,
as well as our annual Cardiovascular Research Day Symposium. Training is monitored by formal mentoring
committees; and informal support networks exist to guide trainees towards competing for career development
awards with goal of developing into independent cardiovascular researchers. Steering and External Advisory
Committees are in place to monitor the Program for its effectiveness in achieving Program objectives.

Public health relevance
Project Narrative Cardiovascular disease remains the leading cause of morbidity and mortality in the United States, and cardio- metabolic conditions are the emerging threat with the epidemic of obesity and metabolic syndrome. The key objective of this training program is to prepare the next generation of physician-scientists and scientists to apply principles in cardiovascular research to understand the underlying mechanisms and develop strategies to prevent or treat these diseases, with a focus on quality, access and affordability of health care. This program seeks MDs, MD-PhDs or PhD post-doctoral trainees to train with established mentors pursuing high impact cutting edge research, towards the goal of becoming independent physician-scientists and researchers.